Gene Therapy For Immune Deficiencies

This project involves the conduct of therapeutic clinical trials for the treatment of inherited immune deficiencies using hematopoietic stem cell therapies. We recently completed a clinical trial of gene therapy for the inherited deficiency of the phagocytic cell immune system known as chronic granulomatous disease (CGD). Patients with CGD have defective circulating blood neutrophils that fail to produce microbicidal hydrogen peroxide. They suffer from recurrent life threatening infections and premature mortality. Three years ago we completed a phase I study of gene therapy for the p47phox deficient autosomal recessive form of CGD. In that study we demonstrated that a single cycle of gene therapy targeting cytokine mobilized and purified stem cells could result in production of small numbers (.004% to .05%) functionally corrected neutrophils in the peripheral blood that persisted for 2 to 6 months. Following completion of this first trial, we incorporated a number of technical improvements in the gene transfer technology into a modification of the gene therapy clinical trial and have focused on gene therapy for the X-linked, gp91phox deficient form of CGD. An amended gene therapy protocol for CGD began to enroll patients in April 1998 incorporating these enhancements and was recently completed and a manuscript is in preparation describing these results. Enhanced mobilization of stem cells to the peripheral blood was achieved by using an alternate mobilization regimen of the combination of administration of the marrow growth factors, GM-CSF (Leukine) and FLT3-ligand (Mobist). Improvements in purification of CD34+ stem cells were achieved using the an automated stem cell selection device (Isolex 300I). The use of the fibronectin fragment, CH296 (RetroNectin) in the ex vivo culture and transduction of the stem cells allowed us to reach 60-90% transduction rates (gene transfer) in the stem cells that were reinfused into the patients. Is some of the gene therapy treated patients up to 1 in 400 circulating neutrophils in the peripheral blood demonstrated functional correction following the gene therapy. This peak level of correction occurred at 3 to 6 weeks after therapy and the effect could be sustained for over a year in three of five patients treated with multiple infusions of autologous ex vivo gene corrected CD34+ progenitor cells. These gene therapy studies demonstrate that it is possible to provide a low level partial and transient correction of the CGD defect in patients by gene therapy. While the level of correction is not a cure and may not be at a level that provides clinical benefit, it represents a very important demonstration of the principle that gene therapy can correct the biochemical defect of CGD in the patient. It may be that even low level and transient correction might provide clinical benefit in the setting of severe recurrent infections. The current study has achieved its scientific goal of demonstrating feasibility. We are in the planning stage of a study to determine if non-ablative marrow conditioning might enhance the level and durability of the effect of gene therapy for CGD. One of the important questions is whether in a clinical setting it is possible to use non-ablative marrow cytoreduction to more safely achieve the engraftment of stem cells. While this question has an impact on achieving success in gene therapy, advances in the use of non-ablative conditioning for allogeneic transplantation have allowed us to explore the potential of this approach to achieve curative allogeneic transplantation for CGD. An ongoing clinical trial was initiated and recently completed in which patient with CGD undergo non-ablative marrow conditioning with immune suppression achieved with a combination of cyclophosphamide, fludarabine and anti-thymocyte globulin. The patients then received a transplant with purified CD34+ peripheral blood stem cells mobilized from a fully 6/6 HLA matched sibling of the CGD patient. The graft is depleted of most lymphocytes and donor lymphocytes are infused at later time points after transplant to help to establish the donor graft. 5 adults and 5 children were transplanted. 4 of 5 children achieved stable long term engraftment that appears to provide a significant level of protection from infection, and all 5 children are alive and well. While 4 of 5 adults achieved long term engraftment, there were three deaths, one from complications of graft versus host disease, one from pneumococcal pneumonia at 1 year post transplant, and one from complications from a second fully ablative salvage transplant procedure. Of the two adult CGD transplant patients who are fully engrafted, one patient continues to have moderate graft versus host disease. We conclude that non-ablative matched related allogeneic transplant is a reasonable option in pediatric patients with CGD and a high risk of mortality from recurrent infection. Currently adults appear to have a high risk of complications from graft versus host disease and delayed recovery of lymphocyte immunity. A follow up trial of non-ablative allogeneic transplantation in children with high risk CGD is just beginning using modified procedures to enhance engraftment and reduce the risks of graft versus host disease. A clinical trial of ex vivo gene therapy for X-linked severe combined immune deficiency is in review and should begin in the next fiscal year. This trial uses the methodology developed for the CGD gene therapy trial, and will focus on the treatment of XSCID patients without a matched sibling who have failed to achieve significant benefit from the standard therapy of a haploidentical marrow transplant from a parent.